Imaging Biomarker Core

IBM Core Summary/Abstract
Since 2005, the Imaging, Methodology, and Statistics (IMS) core described in earlier cycles of
this PPG has provided projects with broad support for PET and MR image analyses, data
management, and statistical expertise. Progress over the last 15 years has resulted in the
evolution of a comprehensive data analysis infrastructure for PET and MR imaging studies in
Alzheimer’s disease (AD) and related disorders at the University of Pittsburgh, supported by a
large number of faculty and staff who have developed considerable technical expertise in the field
of AD imaging. In this cycle (PPG4), the previous functions of the IMS core (PPG1-3) will be more
efficiently divided across the Imaging Biomarkers and Methodologies (IBM) Core described here
and the Biostatistics and Data Management (BDM) Core. The IBM Core will concentrate imaging
resources and expertise to provide PPG4 projects and investigators with a broad range of imaging
tools, methods, and technical expertise to support PET, high-field (3T) and ultra-high field (7T)
MR imaging. The IBM Core will be responsible for the acquisition, analysis, and quality control of
all PET and MR image data collected in support of PPG4 projects, and will maintain a direct
interface with the BDM Core to facilitate the efficient transfer of raw and processed PET and MR
images and imaging outcomes, which include PET indices of amyloid, tau, and astroglial
pathologic burden, as well as 7T MR measures of cortical thickness, regional volumes, and
cerebrovascular disease burden, to the BDM Core, which we will assist with tasks related to the
interpretation and dissemination of images and image outcomes. The IBM Core will continue to
hold weekly meetings with other PPG researchers to discuss PET and MR data acquisition,
processing, analyses, and general methodology issues, as well as to identify and adequately
resource opportunities to develop novel PET and 7T MR imaging methodologies with the potential
to positively impact PPG4 research and the field more broadly. The IBM Core will also continue
to provide training to students, post-doctoral fellows, and faculty in neuroimaging methods.